Watts Rising: A Vision for a Healthier Watts

ABSTRACT
Watts is a community in Southeast Los Angeles that has faced systematic disinvestment, discrimination,
and resource deprivation, resulting in health disparities across multiple domains including high rates of
diabetes and obesity, high pollution burdens and limited employment opportunities. Watts residents,
almost exclusively people of color, (73% Latinx and 25% Black/African American), have a life expectancy
twelve years lower than other parts of Los Angeles, largely due to decades of neglect the community has
faced. This proposal builds on the work of the existing Watts Rising Collaborative (WRC) to address this
neglect through a community-led approach to develop and evaluate an intervention that will address
two primary structural factors that contribute to these disparities and health outcomes: access to
resources and food insecurity and economic instability. The project will be developed through a
partnership between the Housing Authority of the City of Los Angeles, the University of California Los
Angeles and Charles Drew University as well as the 50 members of the WRC and Watts residents. We
will employ an intervention mapping process to refine an intervention that will develop a network of
community gardens that will provide opportunities for increased access to healthy foods, green space
and physical activity as well as entrepreneurial opportunities for businesses utilizing food from the
gardens. Ultimately, we anticipate the intervention will decrease rates of preventable chronic disease in
Watts and provide opportunities for workforce development. This intervention has the potential to
positively affect the entirety of the Watts community of approximately 40,000 residents.

Public health relevance
Specifically, the project aims to assess interventions that enhance the built environment and improve economic wellness, ultimately improving mental health outcomes. The built environment intervention will enhance quality of life, perceived safety, accessibility to outdoor and public spaces, and foster community cohesion. The financial wellness intervention will promote an enhanced quality of life, community cohesion, and lower stress levels. The result of each intervention will be improved emotional well-being at the individual level.